Nucleation and dynamics of exocytotic fusion pores

PROJECT SUMMARY:
In neurons, synaptic vesicles (SV) packaged with neurotransmitter fuse with the plasma membrane to release
their content that is sensed across the synaptic cleft. Release is triggered by a local increase in the calcium
concentration following depolarization. Release kinetics comprise a synchronous phase (0.1-5 ms after calcium
elevation), and a much slower asynchronous phase (~100 ms). How membrane fusion can be triggered so
rapidly and how the kinetics are regulated are not well understood. Hormones are released in a similar fashion,
with multiple kinetic phases, using some of the same protein machinery, via fusion of hormone containing
secretory granules (SG) with the plasma membrane. The initial ~1-3 nm wide connection between the fusing
compartments, called the fusion pore, can flicker open-closed in succession before either closing permanently
(transient fusion) or dilating fully. There is large variability between cell types (pore open times span ~100 µs
to 10s of s) and within the same cell (some pores flicker, some dilate abruptly). Pore flickering is modulated by
physiological inputs such as stimulation strength, with important consequences about what is released (only
small cargo can escape through a small pore), on what time course, and how exocytosis is coupled to
endocytosis. Despite the importance of fusion pores in regulating release, very little is understood regarding
mechanisms controlling pore nucleation and dynamics. This is mainly due to difficulties in studying fusion
pores in reconstituted systems with well-defined protein and membrane components that would allow isolating
the role of each. Fusion mediated by exocytic SNARE proteins and their regulators has been reconstituted and
studied for the past 20 years. However, methods that can monitor single reconstituted fusion pores with sub-
ms resolution have been lacking. During the last cycle, we developed such methods for the first time, and
explored mechanisms regulating fusion pores induced by SNAREs alone. In the next cycle, we propose to use
those methods to (1) define the role of SNARE-interacting proteins in nucleation and dynamics of
fusion pores and the selectivity of small pores. To characterize how the calcium sensors for exocytosis
and other essential components of the release machinery contribute to fusion pore properties, we will use
electrophysiology, nanodiscs, engineered cells, single-particle fluorescence microscopy, microfabricated
devices, and artificial bilayers. We will also characterize selectivity of small fusion pores for ions, which is
highly relevant for determining what is released during transient fusion events. We will then (2) dissect
mechanisms contributing to kinetics of calcium-triggered exocytosis. The approaches will be
augmented to allow rapid (~1 ms) [Ca2+] elevation using microperfusion or ultraviolet flash photolysis. These
will enable defining how different sensors and release complexes regulate release kinetics and what determines
the high calcium-cooperativity of release. These fundamental studies will advance our understanding of how
neurotransmitter and hormone release are regulated, with potential impact on human health in the long term.

Public health relevance
NARRATIVE: Neurotransmitters and hormones are released each time a vesicle filled with such cargo fuses with the plasma membrane of a neuron or endocrine cell. The release process is regulated by the speed with which a fusion pore opens and the subsequent evolution of the pore (some pores flicker open and closed repetitively while others open abruptly), but little is understood about molecular mechanisms governing pore nucleation and dynamics. We aim to use recently developed technology to study how fusion pores open and dilate in response to calcium with well-defined membrane and protein components so that the contribution of each component and the overall molecular mechanisms can be understood in detail.